The role of CX3CR1+ antigen presenting cells in T cell selection and central tolerance"

PROJECT SUMMARY/ ABSTRACT
Autoimmunity is defined as the loss of tolerance to self-antigen resulting in the targeted destruction of tissue by
immune cells. Autoimmune conditions are on the rise globally while our knowledge on how autoimmunity
emerges is still limited. The thymus is a highly structured organ that is essential for T cell development and
education. The nature of the gene rearrangements on the T cell receptor (TCR) allows for recognition of self and
non-self-antigens. Positive selection occurs in the thymus cortex where thymocytes receive survival signals when
selected against self-antigen by cortical thymic epithelial cells (cTECs). Negative selection occurs in the thymus
medulla driven by medullary thymic epithelial cells (mTECs), and a diverse repertoire of antigen presenting cells
(APCs) including different subsets of dendritic cells (DCs) and B cells. The signaling strength of the tri-molecular
complex (TCR-peptide-MHC) between APCs and thymocytes dictates cell fate. Thymocytes who react too
strongly to self-antigens are deleted, become anergic or divert to regulatory T cell (Treg) lineage. In optimal
conditions T cell selection prevents the release of autoreactive T cell clones to the periphery a critical process to
prevent the onset of autoimmunity. However, the mechanisms behind the escape of autoreactive T cells to
the periphery in autoimmune conditions are poorly understood, and the study of T cell education in a
primary lymphoid organ is not feasible in humans. Mouse models have demonstrated to be powerful tools
in thymus studies, as several developmental and functional mechanisms are evolutionary conserved. Migratory
and resident APCs are known to drive clonal deletion and Treg lineage in both the humans and mice. CX3CR1
is expressed in a subset of tolerogenic B cells and Mononuclear phagocytes (MNPs): DCs, macrophages and
monocytes. CX3CR1+ APCs present antigen to CD4+ T cells in peripheral organs. CX3CR1+ APCs in the gut
induce differentiation of peripheral Tregs via transcription factor Foxp3. The close interaction of CX3CR1+ APCs
with CD4+ T cells in the periphery lead us to hypothesize whether a similar population of CX3CR1+ APCs resides
in the thymus to drive selection of T cells and may play a role in thymic Treg development. Our preliminary data
shows a population of CX3CR1+ APCs in the thymus capable of antigen specific stimulation of CD4+ T cells in
vitro. The long-term goal of the proposed work is to understand how autoreactive T cells develop and
escape selection mechanisms in the thymus driven by CX3CR1+ APCs and ultimately drive the
emergence of autoimmune disease. Our studies aim to investigate the contribution of APCs to central T cell
tolerance with the goal of finding potential new targets for treatment of autoimmune disease.

Public health relevance
PROJECT NARRATIVE The thymus mediates T cell positive and negative selection to prevent autoimmunity. Migratory and resident antigen presenting cells contribute to thymocyte selection by diverse, sometimes cell specific mechanisms. Our understanding on the emergence of autoimmune pathologies driven by autoreactive T cells who escape tolerance mechanisms, such as central tolerance, is still limited.